Renewal: Short-Term Training for Medical Students in Cardiovascular and Pulmonary Research

PROJECT SUMMARY/ABSTRACT
The University of Florida College of Medicine has a long tradition and record of accomplishments in training
medical students for careers in academic medicine and research. This application is a resubmission of a
competitive renewal of a T35 Grant titled “Short-Term Training for Medical Students in Cardiovascular and
Pulmonary Research” that was first awarded to the College of Medicine in 1981 and is now in its 40th year. The
purpose of the training grant is to provide intensive, short-term (10-week) research experience for twenty first-
year medical students under the guidance of a chosen research mentor. The overarching goals of this proposal
are: 1) create a training program that equips trainees with the initial research skills, knowledge, and expertise to
engage in scientific exploration, 2) provide a roadmap for students to envision a future career pathway in
academic medicine, 3) monitor trainee-related experiences and outcomes that will serve as a foundation for
evaluating the status of the program and for making future improvements, and 4) instill a culture of professional
excellence based on enhancing rigor, reproducibility, and transparency in research.
From among the 1,100 faculty members in the Colleges of Medicine and Engineering, 44 mentors have been
selected for inclusion in this training program based on the quality of their research program and proven track
record of training. A full-time, one-on-one research experience under the tutelage of a mentor is the core
component of the research training. This experience is augmented by a series of enrichment sessions that are
designed to provide fundamental research skills and present a series of potential roadmaps toward a career in
academic medicine. Topics that are covered include training in the responsible conduct of research, research
ethics, biostatistics, research oversight and regulation, preparation of presentations/abstracts/manuscripts, and
an academic career roundtable discussion. Student presentations, with comments from their peers and senior
faculty, are used to improve their skills and enhance their projects both at the onset and conclusion of the
program.
Critical to the success of the training experience is the recent implementation of the Discovery Pathways
Program (DPP) with the medical school curriculum. The DPP is an experiential, small-group seminar series
designed to provide in-depth exposure to an area of particular interest. An essential aspect of the DPP is for
medical students to build a portfolio of accomplishment and scholarship. Spanning the entirety of the medical
school experience, students choose one of eleven tracks that cover a range of topics and interest areas. While
each track has a particular mix of seminar presentations, roundtable discussions, and engagement activities
outside the medical campus, common to all tracks is the requirement for a mentored capstone research project
suitable for publication in the peer-reviewed medical literature. The current training grant serves as the initial
launching point for this effort and the critical element that drives this unique and highly successful program.

Public health relevance
NARRATIVE The purpose of this T35 grant renewal is to provide intensive, short-term (10-week) research training for 20 medical students who will conduct clinical, translational, and basic research projects relevant to the mission of the National Heart, Lung, and Blood Institute. The research will be conducted under the mentorship of faculty members from the Colleges of Medicine and Engineering, who have a proven record of mentoring. The program is designed to attract the most highly qualified University of Florida medical students into careers as physician- scientists in the fields of cardiovascular and pulmonary research.